Genetic and MRI biomarkers of neuroplasticity predict aphasia recovery and phenotypes

Project Abstract
Aphasia is an acquired neurologic language disorder that is among the most challenging long-term disabilities
for stroke survivors, often leading to social isolation and reduced quality of life. Recovery from aphasia relies
on plasticity in residual brain networks. However, neuroplasticity varies substantially across individuals, making
the presence, severity, and phenotype of language impairments challenging to predict. A vital step toward
post-stroke precision medicine is identifying neuroplasticity-related biological markers that can improve
prognostic models and targeted neurorehabilitation therapies for people with aphasia. The proposed research
will test the central hypothesis that individual differences in neuroplasticity, measured through genetic
polymorphisms and longitudinal neuroimaging connectivity biomarkers, will account for significant variance in
post-stroke aphasia recovery. This 5-year project will include three specific aims. Aim 1 is to index
spontaneous recovery by determining relationships between genetic biomarkers of plasticity, longitudinal
neural network connectivity, and changes in language during sub-acute to chronic stroke recovery. Aim 2 is to
identify genetic and MRI biomarkers predictive of chronic post-stroke aphasia severity and phenotypes. Aim 3
is to characterize genetic and MRI biomarkers associated with verbal learning variability in chronic aphasia.
These data will support the development of a larger, multi-site R01 study to examine interactions between
multiple biomarkers of neuroplasticity that inform longitudinal aphasia prognostics and treatment efficacy.
This career development proposal is designed to provide Haley C. Dresang, Ph.D., a clinical neuroscientist
and aphasiologist, with the training required for success as an independent patient-oriented scientist
conducting neurotranslational aphasia research. As a junior faculty member at the University of Wisconsin–
Madison, Dr. Dresang is in an ideal environment with extensive infrastructure to support early-stage
investigator training and research. The proposed career development plan includes both coursework and
mentored training in the areas of 1) MRI neuroplasticity biomarkers, 2) genetic polymorphisms associated with
neuroplasticity, 3) longitudinal clinical trials design and analysis, and 4) professional skills for an independent
translational neuroscientist. To ensure success, she has identified committed, expert mentors in these
disciplines and secured protected time for this work. This award addresses a significant clinical dilemma and
serious gap in neurobiologically motivated aphasia research, while affording the education and mentored
research experience critical for Dr. Dresang to lead an independent aphasia research program.

Public health relevance
Project Narrative Patients with stroke frequently suffer from aphasia, a disorder of expressive and/or receptive language, that can lead to serious health consequences, including social isolation, depression, reduced quality of life, and increased caregiver burden. Aphasia recovery varies greatly between individuals, and likely relies upon the capacity for neuroplasticity, both at a systems level of reorganized brain networks and a molecular level of neuronal repair and plasticity. The proposed work will evaluate genetic and neural network biological markers of neuroplasticity associated with variability in aphasia, with a future goal to improve prognostics and identify therapeutic targets to reduce the long-term burdens of aphasia.